High-parametric flow cytometry cell sorter for human immunology studies.

PROJECT SUMMARY
Flow cytometry is the most commonly used and critical tool for analyzing immune cell populations in tissues,
enabling approximately 18-20 parameter separation of populations and maintaining cell viability. By passing cells
through a stream in which laser excitation is applied, individual populations of cells can be separated into either
96 well plates as single cells, enabling cloning and other applications, or can be enriched as populations in 4-6
separate populations simultaneously. This is the only cell separation technology universally adaptable to multiple
tissues including isolation of rare populations from difficult sites such as peripheral tissues, necrotic tumors, and
organs.
Currently, this cutting-edge technology is not readily available to the Weill Cornell Medical College (WCMC) and
medical center research community. Our current flow cytometry core is at maximum capacity usage for basic
science applications and is booked weeks to months in advance, prohibiting alignment to the needs of clinical
research investigators and basic and translational research directly on patient samples.
Based on a prospective survey of WCMC scientists, we have identified over 12 NIH-funded major users, as well
as a large number of minor users from multiple departments who have requested this instrumentation to advance
their work. The proposed applications are diverse, leveraging the various scientific strengths of a number of
WCMC labs. Some examples include Dr. Ari Melnick's work on understanding human B cell germinal centers,
Dr. Sallie Permar’s understanding of pediatric infections and human vaccine responses and correlates of
protective immunity, Dr. Laura Santambrogio’s ongoing studies on the human MHC peptidome to understand
immune antigen presentation, and Dr. Brad Jones’ investigations into HIV pathogenesis and T cell immune
responses.
The leadership of WCMC is strongly supportive of the acquisition of this instrument, and will provide significant
additional funds beyond those requested in the S10 application. In addition, dedicated space has been allocated
within the Belfer Research Building and Human Immune Monitoring Core, where the instrument will be located
and managed. Overall, we hypothesize that the establishment of a Flow Cytometry cell sorter instrument on the
WCMC campus will be pivotal in driving new scientific insights across a number of projects and disciplines.

Public health relevance
PROJECT NARRATIVE Fluorescence Activated Cell Sorting (FACS) technology permits high-dimensional analysis of cells, and population enrichment and separation along a number of parameters and facilitates in-depth interrogation of individual populations, cell separation and isolation for downstream additional functional analytics, genomics, phenotyping and culture. This state of the art (SOTA) technology is currently unavailable to dozens of scientists at Weill Cornell Medical College who need this technology in real time in the medical center, whose research would be potentially transformed by access to a sorter for human specimens. We are thus requesting funds for the acquisition of a cell sorting instrument, to be installed and managed in the Human Immune Monitoring Core, a newly established, well managed, and closely advised key facility at Weill Cornell Medical College.